Development of an Ondansetron Transdermal Patch for Pregnancy-Induced Nausea and Vomiting

Pregnancy-induced nausea and vomiting (PINV) afflicts 50-85% of all pregnancies, of which there
are 4 million each year in the US alone. Symptoms, often disabling and sometimes severe and
unremitting, occur in 80% of sufferers at random times throughout the day, and typically persist
throughout the first and early second trimester, and occasionally much longer. Currently available
treatments, of which only one is FDA-approved, require oral ingestion and retention of medication
multiple times daily, which can be challenging in the face of unrelenting nausea or vomiting.
The proposed SBIR Phase I project aims to complete the pharmaceutical development of a
transdermal dosage form designed to deliver the 5-HT3 antagonist anti-nauseant ondansetron to
treat pregnancy-induced nausea and vomiting (PINV). The final product will be a small patch
which is applied once or twice weekly. Following an initial lag period on the first day of dosing, the
product will deliver therapeutic quantities of drug continually throughout the period of application
without the need for oral administration.
Our product is intended to provide a safe, effective, and tolerable outpatient treatment for
PINV that avoids the oral route of administration entirely. It is based on a proprietary skin
penetration enhancement system which increases ondansetron absorption through the skin by
450-fold over unenhanced formulations. In a pre-IND meeting, we have obtained FDA’s guidance
on the path to regulatory approval. Once approved, this novel product will present a cost-effective,
convenient alternative to pregnant women suffering with PINV.
The aims of this proposed SBIR Phase I program for a transdermal ondansetron product are to:
1) complete optimization of product design, 2) produce pilot scale patches which conform to
product specifications, and 3) conduct IND-enabling dermal safety studies. Upon successful
completion of this program, an SBIR Phase II follow-up program will be proposed that will include
filing an IND, scale-up and manufacturing of clinical suppllies, and conducting a clinical
pharmacokinetics proof-of-concept study in healthy volunteers, while in parallel performing a
repeat-dose dermal toxicity study in minipigs to support longer-term clinical studies in pregnant
women.

Public health relevance
Pregnancy-induced nausea and vomi�ng (PINV) aﬀects up to 85% of pregnant women (2-3 million/year), typically for 10-15 weeks or longer; symptoms, which can be severe, o�en occur unpredictably. While most pregnant women can tolerate their symptoms with dietary modiﬁca�ons or the approved pyridoxine + doxylamine combina�on, a sizable minority (10-20%) require more eﬀec�ve medica�on. The annual US economic impact of PINV – therapeu�c interven�ons, lost workdays and even hospitaliza�ons if pa�ents are inadequately treated -- is considerable and may exceed $1 Billion. Ondansetron has proven to be highly eﬀec�ve and remains a drug of choice amongst many Obstetricians, but oral administra�on mul�ple �mes daily can be challenging during intense periods of nausea. InteguRx seeks to cimcumvent the need for oral medica�on in PINV by developing a transdermal ondansetron patch for which it hopes to seek regulatory approval.